Experimental Design of a Social Security System in Yucatan

DESCRIPTION (provided by applicant): The project will design, implement, and evaluate a Social Security program in the state of Yucatan, Mexico with a randomized control trial methodology. The Social Security program will be phased in over a three year period, allowing for the judicious choice of treatment and control groups and baseline and follow-up measurements. The proposed program will include both a monthly cash transfer and a health component. In order to ascertain the optimal design of the program, the effects of each component of the program on the health and well-being of elderly recipients will be evaluated. Program parameters will be varied experimentally and their effects will be evaluated. Interventions include anemia treatments, providing health care access, means testing, frequency of benefit payments, and variation of age eligibility rules. A broad spectrum of outcomes will be considered, including health behaviors, dietary practices, physical performance measures, functionality, and selected biomarkers; health care utilization and expenses; cognitive capabilities; social contacts, consumption, financial transfers, mental health, assets and income. The experimental set-up will be used to shed light on key behavioral parameters, such as the effect of financial resources on health and nutrition and on health care utilization; the short and long term relation between financial resources and subjective well-being; the importance of hyperbolic discounting; household risk management strategies and consumption smoothing in response to health shocks; intrahousehold transfers; the income elasticity of labor supply among the elderly.

Public health relevance
PUBLIC HEALTH RELEVANCE: The project will design, implement, and evaluate a Social Security program in the state of Yucatan, Mexico with a randomized control trial methodology. Narrative The project will design, implement, and evaluate a Social Security program in the state of Yucatan, Mexico with a randomized control trial methodology. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In many countries, poverty is more prevalent among the elderly than among younger groups of the population, particularly for the elderly who do not have access to social security benefits (Bourguignon et al., 2004). Social security programs for the elderly provide cash transfers, in-kind resources, and/or health interventions (Coady et al., 2003). There is only limited evidence of the impact of these programs on the health and well-being of recipients and on behavioral outcomes that these types of programs may be causing. We propose to conduct a unique experimental study of the design of a social security program for the elderly by designing and implementing a social security program for the elderly in the state of Yucatan, Mexico, and evaluating its impact through a randomized control trial methodology. The study will include both a cash transfer and a health intervention. To ascertain the optimal design of the social security program, we will evaluate the effects of each component of the program on the health and well- being of elderly recipients, experimentally varying different parameters of the program and evaluating their effects. A large number of effects are possible; we will study a number in this project, leaving others for later study. The cash transfer may lead to crowd-out of private transfers and most likely will affect intrafamily transfers; it may lead to more property crime because some elderly who had no cash to speak of in the past may now become targets; it will most likely affect subjective well-being (e.g., a reduction in depression), but it is hard to say a priori how much of an effect there will be; it will affect the resilience of elderly to the financial consequences of a health shock, but we do not know how much of an effect there will be and how, for instance, intrafamily risk-sharing mechanisms will be crowded out by a social security payment. The cash transfer may also affect health, in particular, mortality. As we will argue in Section D, there are examples of natural experiments where mortality seemed to respond relatively quickly to a change of circumstances. How much that will happen here is an open question, but it should shed more light on the relation between one's financial security and health and mortality. The program also includes health interventions, and the experimental nature of the program will allow us to gauge the effectiveness of the health interventions. (Interventions will be aimed at reducing anemia and hypertension, and an experiment will be carried out to provide free health insurance.) The specific aims of the proposed project are to: 1. Design a non-contributory social security program for the elderly population in the State of Yucatan, Mexico, involving a cash transfer and health interventions (including the provision of free health care for the uninsured and referrals to primary care services for elderly recipients identified as anemic or hypertensive). 2. Identify program parameters and implementation mechanisms that can be experimentally varied to improve effectiveness among different subgroups of the targeted population, including: • Frequency of payments of the cash-transfer (monthly vs. bi-weekly payments); • Method of payment of the pension (cash vs. vouchers vs. debit cards); • Health interventions. 3. Measure the effects of the program on the health, nutrition, and well-being of elderly recipients. In particular, we will consider: selected biomarkers; dietary practices; self- reported health; stress; depression; food security and availability of food at the household level. 4. Exploit the experimental set-up to shed light on key behavioral parameters, in particular changes in: • Smoking and alcohol consumption; • Health care utilization and out-of-pocket health expenditures; • The level and intertemporal pattern of household consumption; • Financial and in-kind transfers between beneficiaries and children and neighbors; • Household risk management strategies and consumption smoothing in response to health shocks; • Intrahousehold transfer of resources; • Effects on economic activity of older workers; • Importance of hyperbolic discounting. 5. Design means-testing mechanisms for poverty programs for the elderly. Work on the project started in October 2007 with funding from the State of Yucatan1, RAND, and NIH. This initial funding has allowed us to build a data collection infrastructure (described in section D), to design and implement the first phase of the program, to develop and test the survey instrument, and to carry out baseline data collection and one follow-up. We are requesting additional funding to cover half of the cost of continued data collection2 , to carry out further experiments with treatment and control groups, to carry out analyses on the data collected along the lines sketched above. Data collected in the project will be made available to the research community at large within a year after the data have been collected. This proposal requests support for work after March 1, 2010. 1Research activities to date have been supported by a seed grant from the RAND Center for the Study of Aging, by the program project "Health and Economic Determinants of Retirement," by the R21 project "Design and Evaluation of a Social Security Program for Oldest Old in Yucatan" (1 R21 AG033312-01), and by the State of Yucatan. The budget justification provides more detail about funding received to date for this research study and what is requested as part of this proposal. 2 The budget justification contains more details. The State of Yucatan covers the other half.